Epigenetic Checkpoint Regulation of Naive T-cell Quiescence and Peripheral Tolerance

Epigenetic checkpoint regulation of naive T-cell quiescence and peripheral tolerance
Maintaining the quiescence of autoreactive naïve T cells and preventing them from reacting to self-antigens
are crucial for T-cell peripheral tolerance, contributing to immune homeostasis and suppression of autoimmune
diseases. We seek to understand how this process is regulated by T-cell-extrinsic and -intrinsic mechanisms.
The former includes regulatory-T-cell-mediated immunosuppression, and the latter covers checkpoint regulators
of conventional naïve T-cell activation and effector differentiation. These cell-intrinsic negative mechanisms re-
main to be fully explored, given that causes of numerous autoimmune disorders are still elusive, despite signifi-
cant progress in our understanding of regulatory T cells and the final effector stage of inflammation and damage.
Immunogenetic studies suggest that environmental factors, such as nutrients, significantly impact the im-
mune system. However, how T-cell homeostasis and immune tolerance are programmed by nutritional cues is
not well defined. Although routinely considered permissive factors, they can profoundly affect T-cell metabolism,
signal transduction, and gene regulation, raising questions about how they shape T-cell peripheral tolerance. To
explore this, we searched for cell-intrinsic checkpoint regulators of conventional T-cell reactivity to self-antigens.
This led to the discovery of the ascorbate transporter Slc23a2 as a negative regulator of the activation and
effector differentiation of naïve T cells, independent of regulatory T cells. We confirmed that Slc23a2 contributes
to high levels of T-cell ascorbate. Although ascorbate plays several biochemical roles, we propose its activity via
TET methylcytosine dioxygenases (or DNA demethylases) in maintaining naïve T-cell quiescence and restricting
activation and differentiation to effector T cells. We also observed reduced ascorbate and increased DNA meth-
ylation in naïve T cells from aged animals and humans, suggesting this axis prevents spontaneous T-cell acti-
vation and effector differentiation during aging that cause inflammaging.
We plan to test the hypothesis that the ascorbate-TET axis acts as a checkpoint regulator, restricting the
activation and effector differentiation of autoreactive naïve T cells in response to self-antigen stimulation. We will
approach this from several angles. First, we will determine how ascorbate deficiency in T cells causes low-grade
chronic autoimmunity, akin to inflammaging. Then, we will establish the role of the ascorbate-TET axis in regu-
lating T-cell activation and effector differentiation. Finally, we will unveil how the ascorbate-TET axis acts step-
wise to suppress naïve T-cell activation and differentiation into effector T cells upon TCR stimulation.
Successful completion of our study will reveal a crucial nutrient-epigenetic axis involving cell-intrinsic ascor-
bate and TET-DNA demethylation in maintaining naïve T-cell quiescence and peripheral tolerance, particularly
in suppressing T-cell inflammaging-like autoimmunity. The mechanistic insights gained in this project could en-
hance the diagnosis, prevention, or treatment of autoimmune diseases, especially during aging.

Public health relevance
Epigenetic checkpoint regulation of naive T-cell quiescence and peripheral tolerance Preventing naïve T cells from reacting to self-antigen stimulation is crucial for maintaining peripheral immune tolerance. However, the cell-intrinsic gene regulatory network managing this process remains unclear. Based on preliminary results, we propose to determine how intracellular ascorbate acts on TET-dependent DNA demethylation to limit naive T-cell activation and effector differentiation in response to self-antigen, aiming to enhance the fundamental understanding of T-cell peripheral tolerance for the diagnosis, prevention, and treatment of age-related autoimmune diseases.